Imaging-based Indentification of Premature Ventricular Contraction-mediated

The cause of premature ventricular contraction (PVC)-mediated cardiomyopathy is unknown.
The estimated prevalence of PVCs is high in the general population with reported 40-75% on
ambulatory monitoring. PVCs are often considered benign, but may be associated with
increased risk of sudden death or associated with chest pain, syncope, or heart failure,
especially when structural heart disease is present. A long-term study on patients with relatively
low PVC burden showed no difference in survival. However, high PVC burden is associated with
lower left ventricular function in patients with and without structural disease. Unfortunately,
suppressing PVCs by ablation or antiarrhythmic medications do not always improve ventricular
function in patients. Animal models have showed that bigeminy pacing near the apex could
induce a cardiomyopathy that is reversible without myocardial structural changes. However,
these models do not explain the lack of cardiomyopathy development in some human subjects
with frequent PVCs such as bigeminy. We propose that frequent pathologic PVCs lead to PVC-
induced cardiomyopathy in normal hearts and PVC-worsened cardiomyopathy in hearts with
abnormal tissue characteristics. The pathologic versus benign PVCs can be determined by LV
function during PVC, which is quantitatively assessed using advanced real-time cardiac
magnetic resonance imaging (MRI) techniques. LV function during PVC is likely a result of a
combination of factors including PVC site of origin, coupling interval, and conduction time
through the myocardium. Together with tissue characterization of the ventricular myocardium by
cardiac MRI and electroanatomic voltage mapping, this proposal seeks to identify hemodynamic
and structural features in PVC-induced or worsened cardiomyopathy in order to better select
patients for treatment.

Public health relevance
Premature ventricular contractions (PVCs) are prevalent in the general population and they are often considered benign, but frequent PVC may impair heart muscle function in certain individuals. It is often unclear when patients present with heart failure and PVCs if removing PVCs through an invasive procedure or suppressing them with medications would improve heart function. This study is aimed at studying PVCs with new imaging techniques to identify which PVCs are pathologic and should be treated and which PVCs are benign and can be left alone.